Role of individual and hospital factors in quality of care for children in EDs (Div Supplement)

Project Abstract
This diversity supplement is requesting a 1-year supplement for Dr. Kemal, a pediatric emergency medicine
fellow, to assist with her next immediate career stage of becoming a K-funded emergency medicine youth
violence investigator. This supplement will provide key opportunities to strengthen her statistical analytic skills
using large datasets, advance her expertise in qualitative methods, build foundational grant-writing skills, and
receive mentorship from established clinician investigators. Within the foundation of an R01 focused on
systems to improve care for children presenting to general EDs, Dr. Kemal will build analytic expertise using
large databases by identifying ED touchpoints for intervention for youth with violent injury, in addition to
developing expertise in qualitative data collection and analysis by determining the barriers and facilitators to
delivering ED-based interventions. This work will identify critical opportunities for intervention for youth
presenting to the ED with violent injuries and strengthen our understanding of where and how structural
resources should be deployed, including funding for workforce development and hospital-based intervention
programs. At the end of this supplement, Dr. Kemal will have the both preliminary data and the essential
research and grant-writing skills to prepare a K23 submission to implement an ED-based intervention to
decrease recidivism and adverse mental health outcomes for youth with violent injuries.

Public health relevance
Project Narrative The proposed work is relevant to public health and to the mission of the NICHD to improve child and adolescent health, and reduce disparities in care. Although most children receive emergency care in general emergency departments (EDs), national studies have shown that pediatric preparedness is low. Presence of a pediatric emergency care coordinator (PECC) is associated with increased preparedness, but limited data are available to assess the association between PECC status, quality of care and outcomes for children. This work will address this knowledge gap to identify actionable strategies to improve care for children receiving care in general EDs.